Defining tumor-infiltrating B cell signatures associated with T cell mediated antitumor immunity in human lung adenocarcinoma

Lung cancers are the most common malignancies and are the leading cause of cancer-related deaths worldwide.
Immunotherapies are transforming treatment regimes, and trials conducted in lung cancer have already
demonstrated improvements in long-term survival outcomes. However, existing therapies are not effective in all
patients, stressing a need to better characterize the complex molecular and immunological processes associated
with treatment responsiveness and disease progression. Although T cells have been the primary target of
immunotherapies in lung cancer, there is a growing appreciation that T cell-mediated anti-tumor immunity can
be influenced by actions of other immune cells within the tumor microenvironment (TME). Tumor-infiltrating
(TI) B cells have been shown to have dual roles in tumor progression generally, but in non-small cell lung
cancers (NSCLC), specifically adenocarcinomas (LUAD), particular B cell subsets have been shown to both
promote T cell anti-tumor responses and positively impact long-term survival outcomes. Indications of a role for
specific antibody (Ab) responses in LUAD have also recently been reported, including evidence of focused tumor
antigen-specific responses. However, characterizations of anti-tumor B cells and their functional signatures have
been limited by the study of only a small number of pre-selected surface markers in relatively small numbers of
patients. Nonetheless, it is evident that B cell-mediated roles in LUAD tumor progression are variable among
patients, and indicates that a more comprehensive and integrated characterization of TI B cell phenotypic
variation and the associated effects on the anti-tumor T cell response has great potential to inform our
understanding of disease progression, as well as the development of novel, potentially personalized, therapies.
The overall goal of this proposal is to define TI B cell signatures that are associated with the T cell-mediated
anti-tumor response in human lung cancer. To achieve this goal, we will leverage several cutting-edge
techniques to first comprehensively profile lymphocytes (B and T cells) in tumor and paired normal tissues from
a large cohort of early-stage LUAD patients, including the first pairing of this type of data with Ab repertoire
sequencing as a means to interrogate critical functional Ab response signatures in LUAD B cells. Importantly,
the single-cell profiling approach proposed will leverage B cell markers already determined to be associated with
long-term LUAD survival outcomes, so that distinct functional B cell profiles and their associations with TI T cells
can be identified specifically in the context of disease progression (Aim 1). These large-scale statistical
associations will be validated and then serve as a framework for conducting functional in vitro culture and serum-
based analyses to assess whether prognostically favorable B cell subsets identified have distinct functional
phenotypes, associate with tumor antigen-specific Ab responses, and have differential effects on T cell activation
and effector function (Aim 2). Successful completion of this project will facilitate novel discovery and biomarkers
critical for the development of novel therapeutics in human lung cancer.